NAD Metabolism and Signaling

Project Summary
The 2024 FASEB NAD Metabolism and Signaling Meeting serves to unite researchers and clinicians
who share the desire to elucidate NAD-dependent mechanisms and to evaluate the potential for NAD-based
approaches for improving human health. This meeting overcomes barriers that inevitably form around sub-
disciplines and promotes new collaborations. The meeting attracts attendees who work in different fields and
retains a clear focus and interactive climate. This promotes genuine discourse, sincere collaboration, sharing
of unpublished data, and exchange of burgeoning ideas. In turn, this meeting has accelerated the pace of
discovery, expansion of NAD research into new areas, and resulted in forward progress of the field. In 2024 we
seek to accommodate this growing and dynamic field, to push for technical breakthroughs, to obtain clarity in
measurement standards and evaluation criteria for human trials, and to welcome investigators from new areas
of research into our community. We are hosting new topic-specific sessions for cancer and neurobiology, and
will pilot a pre-meeting event for trainees called Precursors. We are also hosting a dedicated speaker session
for clinical trials, as well as a professionally moderated panel with the objective to develop discourse and
consensus around how to approach studies of NAD in human health.
The breadth of this meeting encompasses a vast diversity of biological topics and diseases, as well as
includes the entire NAD metabolome such as NAD+, NADH, NADP+, NADPH, NaADP, ADP-Ribose, cyclic
ADPR, Methylated-Nam, and pyridone nucleotides. The meeting further hosts researchers who use
approaches that scale from atomic structural analyses to human physiology. Represented fields include
chemistry, biochemistry, molecular and cell biology, preclinical organismal models, synthetic biology,
engineering, and human trials. Thus, the major benefits of this meeting are the integration of ideas and
collaborative outcomes across disciplines, as well as clarity and leadership for standards in NAD research.

Public health relevance
Project Narrative NAD Signaling and Metabolism is central to human biology; mediating key aspects of healthy physiology and aging but can be usurped in diseases such as cancer. The Federation of American Societies of Experimental Biology (FASEB) sponsors a biennial conference that unites researchers and clinicians with shared interest in understanding NAD-dependent mechanisms and in evaluating the potential of this molecule for improving human health. With this R13 application, we seek funding to support attendance and increase engagement of highly meritorious early-stage scientists and trainees.